Control of Forebrain Neuroblast Migration in Mouse and Human

The goal of the proposed project is to examine molecular mechanisms that regulate long-range neuroblast migration and then dispersal within existing circuitry of the perinatal and postnatal forebrain. In human infants, V-SVZ neurogenesis supplies neuroblasts to two long-range pathways, the rostral migratory stream (RMS) to the olfactory bulb and the medial migratory stream (MMS) to the ventromedial prefrontal cortex (VMPC). The MMS is unique to humans, but the RMS is found in most mammals. Studies of the mouse RMS reveal compact “chains” of migratory neuroblasts surrounded by a dense meshwork of astrocytes. However, it is not clear which signaling mechanisms establish and maintain controlled, large-scale and long-range tangential migration or the distribution of new neurons to their target integration site. Eph-ephrin signaling is a common mechanism used in development to coordinate axon guidance, cell migration, boundary discrimination and cell segregation through adhesive and repulsive cell-cell interactions. During mouse postnatal development, RMS neuroblasts, which are regionally specified with prescribed interneuron subclass fate, display differential Eph/ephrin expression profiles. Absence of the most promiscuous of the Eph receptors, EphA4, results in severe disorganization of RMS neuroblasts/astrocytes and aberrant neuroblast migration, with significantly fewer neuroblasts reaching the periglomerular layer of the olfactory bulb. The heterogeneous expression of cell surface Ephs/ephrins by neuroblasts is reminiscent of heterogeneous Eph/ephrin expression profiles that support topographical mapping of retinotectal/thalamocortical axons. The proposed experiments are designed to determine if Eph-ephrin networks are pre-determined in progenitor subpopulations, contribute to the saltatory migration of neuroblasts and ultimately provide required cues for topographical mapping within forebrain regions. In Aim 1, extensive single cell transcriptomic and proteomic analyses will be used to identify progenitor subtypes and model higher order cell-cell interactions in the mouse RMS. In Aim 2, single cell transcriptome and proteome analysis of Eph and ephrin expression will be used to identify subpopulation distribution in the OB. In Aim 3, tissue clearing and immunolabeling techniques, together with MR data, will allow 3D modeling of the human perinatal MMS and RMS, including cell-specific expression of Ephs and ephrins (and activated forms). The R21 exploratory mechanism is used to initiate studies on long- range neural progenitor migration pathways that persist after birth; the dysfunction of which may be linked to neurodevelopmental disorders.

Public health relevance
Long-range transit of new neurons through the anterior forebrain continues in the mammalian and human brain after birth, providing target regions with extended plasticity during postnatal brain development. Molecular cues that direct newly generated neurons along precise pathways to their final site of integration are only partially understood. The proposed experiments begin to address molecular interactions that orchestrate postnatal forebrain migration, coordinate pathway choice selection and ultimately provide topographical cues necessary for target region distribution in the mouse olfactory bulb and human prefrontal cortex.